Proteomic markers of early and late stage pulmonary fibrosis

PROJECT SUMMARY
Interstitial lung disease (ILD) is a chronic respiratory illness that can progress to a fibrotic subtype with ongoing
aberrant wound healing that occurs in the lung’s epithelium, dysregulated collagen deposition, and
architectural distortion that impairs the alveolar-capillary barrier. The most common type of fibrotic ILD is
idiopathic pulmonary fibrosis (IPF) which has a poor median survival and is a major reason for lung
transplantation. Drugs that are currently approved for IPF slow disease progression but have significant side
effects that can make them poorly tolerated by patients. Majority of IPF clinical trials have tested therapies in
patients who already have a significant burden of fibrosis in the lungs. To have a significant impact on
attenuating disease progression, there is a need to identify novel and tolerable therapies for IPF at all disease
stages, from early to late stage. A major step forward to testing therapies that prevent IPF is identifying
individuals at higher risk of developing disease. It should be non-invasive assessments that (1) have minimal
harm in humans, (2) can identify those at risk of developing IPF, and (3) identify those with a more progressive
form of IPF that would benefit from earlier therapeutic interventions. By addressing this major knowledge gap,
it will facilitate clinical trial enrichment and ensure adequate power to effectively test drugs and risk factor
mitigation aimed at prevention. Our group has identified plasma proteomic biomarkers that perform excellently
at predicting survival in IPF. Many of these proteins also associate with subclinical radiological markers of lung
injury and fibrosis in non-diseased adults, and thus are promising markers that can be used to identify
individuals at risk of developing pulmonary fibrosis. We propose to: (Aim 1) identify and validate proteomic
biomarkers that are predictive of worse short-term survival in IPF, (Aim 2) test whether plasma proteomic
biomarkers are predictive of future pulmonary fibrosis risk in non-diseased adults, and (Aim 3) identify
molecular features of early and later stages of pulmonary fibrosis by incorporating multiple omics platforms in
blood and lung tissue samples. Accomplishing the aims of this proposal will identify blood-based proteomic
biomarkers that can be used to identify at-risk adults and enroll in preventative clinical trials.

Public health relevance
PROJECT NARRATIVE There is a critical need to identify new therapies for idiopathic pulmonary fibrosis (IPF) as current treatments target later disease stages and are often poorly tolerated. Thus, clinical trials are needed that test therapies aimed at preventing fulminant lung fibrosis in at-risk individuals and necessitates tools to ensure cohort enrichment. This proposed study will identify candidate blood-based proteomic biomarkers that (1) associate with radiological markers of subclinical lung injury and fibrosis and are predictive of shorter-term IPF survival, (2) predict future pulmonary fibrosis in non-diseased community-dwelling adults, and (3) identify systemic and lung-specific molecular profiles of early and later stages of pulmonary fibrosis.